Administrative, Mentoring and Education Core

CORE A - ADMINISTRATIVE, MENTORING AND EDUCATION CORE
SUMMARY/ABSTRACT
The Cardiorenal and Metabolic Diseases Research Center (CMDRC) is comprised of multiple components,
including a Pilot Projects Program (PPP), a Mentoring and Education Program, administrative units, and two
Research Resources Cores. Core A provides administrative support and coordinates all Center activities and
interfaces with the NIGMS, UMMC administration, Grants and Contracts offices, departments represented in the
CMDRC, and investigators and trainees of the Center. Specific functions of Core A are: 1) to provide leadership
for enhancing infrastructure, mentoring programs, and core facilities that foster research excellence and lead to
development of an internationally recognized CMDRC; 2) to amplify the overall impact of established CMDRC
Mentoring and Education Programs that facilitate research progress and career development of junior/early
career investigators into independent, funded researchers and effective collaborators on multidisciplinary
research teams; 3) to provide high level administrative support for the PPP and its investigators, with emphasis
on recruiting and mentoring underrepresented minority investigators; 4) to provide high-level administrative
support for core directors, fiscal oversight of all cores and pilot grants, and central services for purchasing; 5) to
provide formative and summative evaluation strategies for progress and effectiveness of all CMDRC programs
and Cores; 6) To further develop and implement mechanisms for effective communication and collaboration
among CMDRC investigators, Core leaders and staff, Internal Steering Committee (ISC), External Advisory
Board (EAB), other centers within UMMC, other IDeA-funded centers, and external partners; 7) to collaborate
with UMMC administration, department chairs, and other IDeA funded programs, including the Mississippi Center
for Clinical and Translational Research (MCCTR), in a Faculty Recruitment Program designed to recruit new
faculty members with research expertise related to cardiorenal and metabolic diseases; 8) to facilitate stronger
pipeline programs for recruiting, training, and mentoring a diverse group of postdoctoral fellows and student
trainees so that they become the next generation of cardiorenal and metabolic disease researchers; 9) to
organize scientific meetings and seminars for the CMDRC, meetings of the EAB and ISC, and an annual
retreat/symposium; 10) to further develop and maintain the CMDRC website, provide assistance to investigators
with their computer systems, insure that all data/documents are securely stored, and install new software and
computer equipment for CMDRC investigators; 11) to ensure that all CMDRC programs, initiatives, policies and
reporting mechanisms are optimally implemented and administered within federal granting agency policies and
deadlines. During Phases 1 and 2, Core A successfully led the CMDRC in developing infrastructure, core
facilities, and mentoring programs that facilitated 29 CMDRC junior investigators being awarded at least 53
extramural grants for >$34 million thus far. During Phase 3, Core A will continue to lead the CMDRC, facilitating
continued growth of the CMDRC's research programs and career development of its investigators.

Public health relevance
CORE A - ADMINSTRATIVE, EDUCATION AND MENTORING CORE NARRATIVE The Cardiorenal and Metabolic Diseases Research Center (CMDRC) has diverse functions and is comprised of multiple components, including a Pilot Projects Program, a Mentoring and Education Program, and two Research Resources Cores. Essential functions of the Administrative, Mentoring and Education Core A are to coordinate and facilitate activities of these components, and provide support for all Center related activities. Core A will further develop and implement mentoring and education programs for investigators and trainees of the Center, and interface with the NIGMS, the University of Mississippi Medical Center (UMMC) administration, the UMMC Grants and Contracts office, the departments represented in the CMDRC, other Centers at UMMC with shared research interests, and partner institutions.